Development of Multilayer Strip Ion Chamber Device for the Measurement of Proton FLASH-Radiotherapy

Ultra-high dose rate radiotherapy or FLASH-RT, has shown the potential to drastically reduce the normal tissue toxicity without compromising tumor cell killing. Proton is the only treatment modality that can treat deep seated target in human body with FLASH-RT. With radiation dose delivered in less than a second, an ultra-fast quality assurance (QA) device is needed to verify the delivery of FLASH-RT. We will develop a multilayer strip ion chamber (MLSIC) device can measure the characteristics of a proton flash beam spot-by-spot including spot position and profile, energy, and absolute dose. The MLSIC device can be used for development, commissioning and QA of proton flash-beams. To develop the MLSIC and achieve the unmet need of QA device for flash-RT, we will perform the research studies to achieve following objectives: 1) Design, optimization, and characterization of a MLSIC device for proton FLASH-RT QA in a synchrocyclotron and an isochronous cyclotron; and 2) Development of proton beam QA algorithm and software for the MLSIC.